Career Enhancement Program

PROJECT SUMMARY
The goal of the Leukemia SPORE Career Enhancement Program (CEP) is to recruit and support new
investigators in the field of translational leukemia research. To accomplish this objective, the CEP program
will provide financial support and mentored research training. The CEP will leverage Institutional strengths to
recruit basic scientists and clinical investigators from varied disciplines to promote multidisciplinary
translational research and will extend current efforts to promote diversity through the recruitment of women,
underrepresented in medicine (URiM), and disabled faculty. The following specific aims are proposed: Aim 1:
We will recruit and support new investigators in the field of translational leukemia research. A total of $185,000
has been committed annually to support CEP researchers. We will fund CEP awardees annually at $75,000
per year for up to two years. Aim 2: We will provide training and mentoring to junior faculty in translational
leukemia research. CEP awardees will be co-mentored by a senior basic science and clinical mentor. In
addition to mentored research training, CEP will work with new investigators to craft an individualized
career development plan that may combine didactic coursework, patient care, and career skills tailored to
their individual goals. Aim 3: We will encourage the participation of women, URiM, and disabled
investigators in leukemia research. Aim 4: We will foster inter-SPORE collaborations. We have established
educational exchanges to provide CEP awardees the opportunity to present their research and meet with the
leadership at a peer Leukemia SPORE Institution.